Regulation of Triglyceride Metabolism by the transcription factor CREB-H

DESCRIPTION (provided by applicant): CREB-H is an endoplasmic reticulum (ER)-bound transcription factor that is highly and selectively expressed only in the liver and the small intestine. CREB-H activation requires a sequential cleavage of its precursor protein by Golgi proteases that liberate the mature N-terminal portion of the protein, which localizes to the nucleus to act as a transcriptional transactivator. CREB-H is induced by fatty acids, the fatty acid oxidation regulator PPAR1, and fasting in the liver, suggesting that it might participate in nutrient and energy metabolism. We demonstrated that CREB-H is required for the maintenance of normal trigylceride (TG) levels in vivo. CREB-H is induced in the liver by fasting and controls a subset of genes that are critical for TG and lipoprotein metabolism. CREB-H deficient mice displayed severe hypertriglyceridemia secondary to inefficient TG clearance catalyzed by lipoprotein lipase (LPL). Genetic profiling revealed that CREB-H deficiency was associated with decreased expression of the LPL coactivators, Apoc2, Apoa4, and Apoa5 apolipoproteins and concurrent augmentation of the LPL inhibitor, Apoc3. Multiple nonsynonymous mutations in CREB3L3 that produced hypomorphic or nonfunctional CREB-H protein were identified in patients with extreme hypertriglyceridemia. We establish CREB-H as a novel transcription factor that governs TG metabolism in rodents and humans. The current proposal aims to further investigate the function and mechanism of action of CREB-H in lipid metabolism. We propose to address the following questions: Aim 1. What is the organ specific function of CREB-H in liver and small intestine, as assessed using conditional CREB-H knock-out mice that selectively lack CREB-H in these organs? Aim 2 and 3. CREB-H and PPAR1 share common target genes that are involved in fatty acid oxidation. What is the functional relationship between CREB-H and PPAR1? Does CREB-H play a role in hepatic steatosis? Given the induction of PCPCK by CREB-H, is CREB-H required for glucose homeostasis? What is the universe of CREB-H targets genes in the liver and intestine? What nutritional and hormonal signals regulate CREB-H, and how CREB-H activation can be achieved at multiple levels, which include transcriptional activation, Golgi translocation, and other post-translational modifications. The mode of CREB-H activation appears be distinct in liver and small intestine, and we will further investigate the precise mechanisms that account for this. Given that CREB-H deficiency resulted in hyperlipidemia, would the augmentation of CREB-H activity be beneficial in the treatment of dyslipidemia? We will address this question by inducible overexpression of constitutively active CREB-H. Aim 4. Finally, what is the molecular mechanism for hypertriglyceridemia caused by mutations in CREB3L3 in patients? We envision that these studies will uncover novel signaling pathways that may lead to the discovery of potential targets for developing novel therapeutics for dislipidemia. PUBLIC HEALTH RELEVANCE: We have much left to learn about the genes that regulate lipid metabolism and contribute to human dyslipidemias. We have recently demonstrated that CREB-H is a novel key transcription factor controlling triglyceride metabolism both in mouse and human by investigating CREB-H deficient mice and identifying CREB-H (CREB3L3) mutations in patients with hypertriglyceridemia. The current proposal aims to define the precise molecular mechanisms that explain the function of CREB-H in lipid metabolism.

Public health relevance
We have much left to learn about the genes that regulate lipid metabolism and contribute to human dyslipidemias. We have recently demonstrated that CREB-H is a novel key transcription factor controlling triglyceride metabolism both in mouse and human by investigating CREB-H deficient mice and identifying CREB-H (CREB3L3) mutations in patients with hypertriglyceridemia. The current proposal aims to define the precise molecular mechanisms that explain the function of CREB-H in lipid metabolism.